Administrative Core

CORE A: Given the size, complexity, duration, and scope involved, Core A will be fundamental
in enabling the successful establishment and operation of the entire program. All costs for
administrative support for the Cores and Projects are included here. Dr. Stokes Peebles will
assume ultimate administrative responsibility for the management of this Core. Administrative,
fiscal services, and clerical support for the entire program will be shared by all Project Leaders,
Core Leaders and Co-Investigators.
This Core will provide and maintain all of the administrative space and functions for the entire
program, including but not limited to, offices for all investigators, an administrative area with
secretarial and administrative support, a copy/work room, and a conference room with up to
date audiovisual amenities. Administrative functions will include ordering of supplies and
equipment, maintenance of all records, keeping and monitoring of budgets, maintenance of the
personnel database for grant effort, interactions with University administrative offices and the
NIH regarding budgetary and other administrative matters, and scheduling and organizing
meetings and presentations. This Core will support all of the computer hardware and software
resources for the administrative and clerical functions of the program.
This Core will coordinate and support the activities of the Internal Advisory Committee and the
External Scientific Advisory Board. The basic functions and objectives of the Core include:
quality management of program resources, integration of the program, oversight of deliverables
within the timeframe, assistance with data management, and leading the vision. To achieve
these objectives, detailed plans are presented for administrative structure and leadership,
project management, external Scientific Advisory Board, and communication/meetings.